Administrative Core

1. SUMMARY (Administrative Core)
The Stanford Alzheimer's Disease Research Center (ADRC) will support goals of the National Alzheimer's
Project Act by serving as a shared resource to facilitate and enhance interdisciplinary and multidisciplinary
research on Alzheimer's disease and Alzheimer's disease related dementia (AD/ADRD). At the Stanford
ADRC, the focus will be on AD and a common ADRD, namely cognitive impairment and dementia linked to
Lewy bodies, Lewy neurites, and the abnormal accumulation and propagation of alpha-synuclein (the Lewy
body spectrum of neurodegenerative cognitive impairment). The Stanford ADRC has adopted a strategy of
deep phenotyping, which draws together multiple levels of biological data on individual participants followed
over time and culminating in brain donation. The Administrative Core provides the administrative structure
needed to direct, facilitate and support the Stanford ADRC mission. It establishes the overall scientific
direction, provides a forum for planning, ensures optimal resource utilization, and assures compliance with
institutional and NIH policy requirements. It will accomplish these goals during the next five years through four
specific aims: (1) Provide an infrastructure that establishes priorities and goals of the P30 Stanford ADRC:
coordinate activities of ADRC cores and committees; ensure compliance with reporting procedures, policies,
and guidelines of the NIH, institutional review board, and other relevant bodies; oversee data transfer to the
National Alzheimer's Coordinating Center (NACC) and other entities; and oversee the transfer of biological
specimens and genetic data to the National Centralized Repository for Alzheimer's Disease (NCRAD), National
Institute on Aging Genetics of Alzheimer's Disease Data Storage Site (NIAGADS), and other collaborating
groups; (2) Stimulate innovative research on AD/ADRD by existing and new investigators, including the
solicitation, evaluation, selection, and monitoring of development projects supported by the Center; (3) Provide
leadership opportunities for the next generation of ADRC leaders; and (4) Promote research, training, and
educational collaborations with other ADRCs, universities, health professionals, caregiver organizations, and
the wider scientific and lay communities.